Community Engagement Core

PROJECT SUMMARY
The translational science spectrum represents each stage of research: pre-clinical, clinical, and implementation
science. Conducting research across the translational spectrum, as proposed in this P01, that meaningfully
addresses alcohol use among young people living with HIV (YPLWH) in Florida, necessitates active
involvement of young people, policy makers and key stakeholders. The Community Engagement Core (CEC)
co-directed by Drs. Nicole Ennis and M. Isabel Fernandez, is tasked with developing and maintaining authentic
partnerships between researchers and YPLWH as well as those with the power and resources to quickly scale-
up scientific discoveries into practice using a community engaged research (CEnR) approach. We have
centralized all of the recruitment, engagement, retention and assessment functions for all of the three studies
into this resources core which is more efficient and cost effective than relegating these functions to the
individual projects as is typically done. From the start, the CEC will engage YPLWH and key stakeholders to
develop: 1) tailored advertisements and insta-stories to post on targeted social media sites and gay dating
apps to promote interest in and recruitment into the three studies: 2) the e-Informed Consents; 3) the SHARE
website; and 4) review of the assessment measures and onboarding procedures. The primary activities of
stakeholder engagement will be: 1) Refine project protocols in conjunction with stakeholders to ensure an
equitable CEnR Context; 2) Manage a web-based portal for bidirectional communication to ensure an equitable
CEnR Process; 3) Evaluate our CEnR Process by assessing stakeholder: a) perceptions of the CEC activities;
b) adoption of new guidelines and polices that result from CEC participation; and c) perceived challenges and
benefits of participation; and 4) Support the recruitment of participants who reflect the characteristics of
YPLWH in Florida. Therefore, the overall goal of the CEC for the SHARE P01 is to serve as a resource for
participant and stakeholder engagement and retention in the research process and to measure the impact of
the CEnR approach across all three projects in this P01. The CEC has two specific aims: Aim 1. Direct and
manage recruitment, engagement, retention and assessment activities associated with implementation of the
three projects proposed in this SHARE P01. Aim 2: Manage and evaluate the dynamic process that supports
sustained engagement and active participation of our stakeholders (i.e., community stakeholder organizations
and Youth Advisory Council) in the research and dissemination efforts of the SHARE P01. The expected
outcome is that ongoing community input and collaborative agenda setting will result in evidence and
interventions tailored to the settings and populations being studied thereby making it more readily accepted by
those communities.

Public health relevance
The SHARE program will develop, test and implement behavioral interventions to improve alcohol use and viral load in youth living with HIV in Florida. At the foundation is a a community engagement core in a state-wide diversity initiative to maximize public health impact.